CELLULAR MECHANISMS OF CEREBRAL VASOSPASM

DESCRIPTION (Investigator's Abstract): Since its recognition over 40 years ago, cerebral vasospasm after subarachnoid hemorrhage (SAH) has remained an enigma to clinicians. The basic mechanisms of arterial narrowing after subarachnoid hemorrhage remain largely undiscovered and current treatments are mostly palliative. Even the term cerebral vasospasm may be imprecise, as controversy exists regarding the role and timing of active vasoconstriction as a cause of decreased vessel caliber. SAH affects over 30,000 Americans annually; in most contemporary series, 15% of such patients suffer stroke or death from vasospasm with maximal therapy. Despite advances in diagnosis and treatment, cerebral vasospasm remains the greatest treatable cause of morbidity and mortality in patients who survive the ictus of SAH. The unifying hypothesis of this proposal is that delayed arterial narrowing after prolonged exposure to perivascular blood occurs in two phases: 1) an initial active phase characterized by reversible, calcium-dependent vasoconstriction, and 2) a subsequent passive phase which is reversible by vasodilators and calcium-independent. Oxyhemoglobin released from peri- arterial thrombus after SAH likely participates in both phases by 1) initial vasoconstriction and 2) subsequent phenotypic changes in cerebral arterial smooth muscle and endothelium, most likely due to cytotoxic injury from lipid peroxidation. The phenotype of injured smooth muscle and endothelial cells is relatively consistent among a variety of injuries, and is manifest by alterations in the expression and response to cytokines (e.g., TGF-Beta, bFGF, IL-1 and endothelin), cytoskeletal constituents and protein synthesis. Physiologic consequences of vascular wall responses to injury may determine the mechanisms of delayed arterial narrowing observed in vasospasm. A series of experiments are proposed to address these hypotheses using two experimental paradigms for vasospasm developed in our laboratory. A simple and inexpensive rat femoral artery model enables chronic application of putative spasmogens or therapeutic agents to arterial wall for regulated periods of time. Parallel experiments in vitro utilizing smooth muscle and endothelial cell cultures allow quantitative assessment of phenotypic changes after exposure to hemoglobin or other substances. The models will be used to characterize the time course and calcium-dependence of contractile mechanisms in evolving vasospasm, to test the effectiveness of various therapeutic strategies (e.g. calcium antagonists, antioxidants) to inhibit arterial narrowing at different intervals, to examine the role and cellular mechanisms by which lipid peroxidation, inflammation and endothelin influence vasospasm, and to characterize alterations in content and distribution of cytoskeletal elements in endothelial and smooth muscle cells after exposure to blood.